Molecular Oncology Training Grant

Abstract
Cancer is a major public health problem worldwide and the second leading cause of death in the United
States. Molecular oncology is an interdisciplinary medical specialty at the interface of medicinal
chemistry and oncology that refers to the investigation of the molecular basis of cancer and tumors and the
development and application of targeted therapies. The field includes a diverse group of investigators with
strengths in cancer stem cells, DNA damage repair and genomic instability, tumor-host interactions, and other
fundamental areas of cancer biology. Areas of scientific focus in our program include basic cancer biology,
computational oncology, solid tumor oncology, and hematopoietic malignancies. The Molecular Oncology
Training Program at Washington University proposes to train the next generation of basic scientists, including 4
predoctoral and 4 postdoctoral trainees per year. Predoctoral PhD students follow the curriculum of the
Washington University graduate school. After passing their qualifying examination, they enter the laboratory of
participating faculty Mentors for 3-4 years of laboratory research to complete their dissertation. Postdoctoral
Ph.D. trainees from around the world apply to participating laboratories. The duration of postdoctoral training
depends on prior experience, but typically they conduct research for 2-3 years before transitioning to an
independent research position. The current training program provides funding for 2 years for each trainee within
a structured program. Trainees receive intensive mentoring and career counseling, participate in program-
specific annual retreat, didactic course and clinical-translational mentoring rotations, journal clubs, and a variety
of specific scientific and career building workshops, as well as training in Methods for Enhancing Reproducibility.
Other courses, including those in Responsible Conduct of Research, are provided by the Washington University
graduate school and the Institute of Clinical Translational Science. Completion of this program will prepare
talented trainees for careers in basic and translational cancer research, to make discoveries that will transform
the diagnosis and treatment of malignant disorders.

Public health relevance
Narrative Cancer is a major public health and economic issue and its burden is set to spiral. In 2022, roughly 1.9 million people will be diagnosed with cancer in the United States. The goal of this grant is to train a new generation of scientists who will make discoveries that enable us to diagnose, treat, and perhaps cure these diseases.